Participatory System Dynamics vs Audit and Feedback: A Cluster Randomized Trial of Mechanisms of Implementation Change to Expand Reach of Evidence-based Addiction and Mental Health Care

Our broad aim is to empower all healthcare stakeholders to provide the highest quality care to all patients.
Our specific aims address the complexities and tradeoffs associated with implementing evidence-based
practices (EBPs) in outpatient addiction and mental health systems. There is scientific consensus about the
best evidence-based psychotherapies and pharmacotherapies (EBPs) to meet the needs of patients with
opioid and alcohol use disorder, PTSD and depression. However, EBP coordination over time, within and
across multidisciplinary teams of providers, is complex and constantly changing. Veterans Health
Administration (VA) policy mandates, national training programs, and incentivized quality measures, have
been insufficient for reaching more than 3 to 28% of patients with the highest quality treatments. In fact,
limited EBP reach is common in health systems and the field of implementation science seeks to address it.
One routine strategy is data auditing with provider feedback (audit-and-feedback; AF), however, the impact
is highly variable. As an alternative, participatory system dynamics (PSD) has been used to explain causes
of complex problems in business management for 60 years. We partnered with frontline staff using PSD to
determine how EBP reach emerges from local resources and constraints, and is determined by system
dynamics, such as delays and feedback. The dynamics of EBP reach were formally specified in differential
equation models, and tested against VA data drawn from a national VA SQL database. We used this
existing enterprise data to tailor model parameters to each care team. PSD models were made accessible
via a `Modeling to Learn' interface and training, during which teams safely evaluated local change scenarios
via simulation to find the highest yield options for meeting Veterans' needs. PSD learning simulations
produce immediate, real-time feedback to the teams who coordinate care, improving day-to-day decisions
and long-term improvement plans. We propose a two-arm, 24-site (12 sites/arm) cluster randomized trial to
test the effectiveness of PSD simulation as compared to more standard team AF data review. We
hypothesize that PSD will be superior to AF for improving EBP initiation and dose (Aim 1). We will test the
PSD theory of change that the effect of PSD on improved EBP reach is explained by improvement in team
systems thinking (Aim 2). To confirm the potential for widespread usefulness of PSD, we will also test the
generalizability of PSD causal dynamics across PSD and AF arms (Aim 3). This study has the potential to
inform a new paradigm, by determining what works to improve health system quality defined as EBP reach,
why it works, and under what conditions. If PSD is effective, study activities will address a national priority to
improve Veterans' addiction and mental health care to prevent chronic symptoms, relapse, suicide and
overdose. Findings from the proposed tests of effectiveness, causality, and generality, could also catalyze
future applications to make a significant public health impact across the continuum of healthcare.

Public health relevance
PROJECT NARRATIVE The most common reasons Veterans seek VA addiction and mental health care is for help with opioid and alcohol misuse, depression and PTSD. Research evidence has established highly effective treatments that prevent relapse, overdose and suicide, but even with policy mandates, performance metrics, and electronic health records to fix the problem, these treatments may only reach 3-28% of patients. This study tests participatory business engineering methods that engage patients, providers and policy makers against the status quo approaches, such as data review, and will determine if it works, why it works, and whether it can be applied in many health care settings to guarantee patient access to the highest quality care and better meet the addiction and mental health needs of Veterans and the U.S. population.